Regulation of the retinal ganglion cell repair program by the mitochondrial protein Armcx1

Abstract
Retinal ganglion cells (RGCs), like most neurons, heavily rely on functions fulfilled by
mitochondria. However, for unclear reasons the sensitivity of RGCs to mitochondrial dysfunction is
higher than in others neuronal types. As a result, many blinding diseases that affect
RGCs are accompanied by mitochondrial impairment. These diseases have very different etiologies
but likely share a common pathophysiology that involves some aspect of mitochondrial
biology. Nevertheless, we have little knowledge of the processes that regulate RGC
mitochondria in vivo which has impeded the development of mitochondria-directed treatments to
promote RGC repair. It is important therefore to understand how RGCs regulate mitochondrial
function and dynamics in vivo as a step in defining regulatory nodes amenable to
pharmaceutical intervention. RGC axons appear to be a prime target for these interventions as they
are especially sensitive to degenerative stress. In these axons that extend to a considerable
distance, it is crucial that mitochondria are appropriately distributed to serve the needs of the
periphery. We recently highlighted the importance of this distribution for RGC repair.
We demonstrated that increasing mitochondrial transport protects RGCs from degeneration and promote
axonal regeneration (Cartoni et al. 2016). This study uncovered a key regulator of
mitochondrial transport; a mammalian specific mitochondrial protein called Armadillo
Repeat-Containing X Linked Protein 1 (Armcx1). We showed that it regulates axonal
mitochondrial transport and that it is both necessary and sufficient for RGC survival
and axonal regeneration after optic nerve injury. These findings suggest that Armcx1
controls the mitochondrial distribution of a mitochondria based RGC repair program. Our long-term
research goal is to elucidate and manipulate the elements of this newly identified
repair program to treat vision disorders. Despite the importance of Armcx1 in RGC repair after
traumatic injury, little is known about the physiological functions of Armcx1 in healthy and
diseased RGCs. Our overall objective is to evaluate how Armcx1 impacts RGC degeneration and repair
as well as to decipher how this protein regulates mitochondrial dynamics and function.
Based on our preliminary results, our central hypothesis is that Armcx1 regulates
mitochondrial transport in demanding conditions such as diseases and/or axonal outgrowth.
Specifically, we hypothesize that Armcx1 is a ubiquitous player in neuroprotection (Aim 1) and that
it is a critical component of the normal RGC axonal outgrowth program (Aim 2). Finally, in an
effort to understand the mechanism by which mitochondria promote RGC repair, we will analyze the
axonal and somatic mitoproteome and identify direct and indirect Armcx1-binding partners in vivo
(Aim 3).

Public health relevance
Project Narrative The degeneration of retinal ganglion cells (RGCs) has been linked to several devastating blinding diseases. Based on our previous work on Armcx1 that revealed its capacity to promote RGC repair after a traumatic injury we will investigate its role in chronic neurodegenerative diseases and axonal outgrowth.